Antibiotic Potentiation by Targeting of a Signal Transduction System

PROJECT SUMMARY/ABSTRACT Staphylococcus aureus is a well-adapted human parasite that is both a commensal and an important pathogen. It is responsible for a wide variety of infectious diseases that range from minor skin abscesses to severe infections and toxinoses requiring hospitalization. S. aureus strains resistant to nearly all ss-lactams, so-called methicillin-resistant S. aureus (MRSA), are a leading cause of healthcare associated and, since the 1990s, community-associated infections. This epidemic of MRSA infections has enhanced the urgency to identify alternative antimicrobial agents for successful treatment. The present application concerns the vra operon that is conserved among S aureus strains and encodes a three-component signal transduction system that senses and responds to cell-wall stress elicited by clinically important antimicrobials. Experimental interruption of the vra operon in a MRSA strain dramatically decreases the minimal inhibitory concentration of oxacillin, a methicillin congener, in MRSA strains. Thus, we wish to explore the idea that vra operon inhibition by small molecules may enhance the ability of ss-lactam antibiotics, such as oxacillin, to kill MRSA strains and treat infections caused by them. Since vra operon expression is induced by cell-wall agents from many chemical classes, the oxacillin potentiators we identify may also enhance activity of a wide variety of other antimicrobials that interfere with cell-wall synthesis such as vancomycin, cationic peptides and daptomycin.

Public health relevance
PROJECT NARRATIVE New antibiotics are needed to treat antibiotic resistant Staphylococcus aureus infections. We have proposed to inhibit a signal transduction system that senses cell wall stress and is necessary for expression of antibacterial resistance phenotypes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Methicillin-resistant S aureus (MRSA) are a leading cause of healthcare associated and community- associated infection. Restoring the sensitivity of MRSA strains to ss-lactams such as methicillin and oxacillin (Ox), a methicillin congener, would provide a novel therapeutic strategy. The vra operon encodes a three- component signal transduction system (VraT, S and R) that senses and responds to cell-wall stress elicited by ss-lactams, thereby enhancing resistance to them. Interruption of the vra operon in an MRSA strain dramatically decreases the minimal inhibitory concentration of Ox in vitro and makes it possible to treat MRSA infections of mice with Ox in vivo. Here we propose that inhibiting the vra operon with small molecules will enhance the ability of ss-lactam antibiotics to treat infections caused by MRSA. Since vra expression is induced by cell-wall agents from many chemical classes, the Ox potentiators we identify will likely enhance the activity of other cell wall-acting antimicrobials (e.g.,vancomycin, daptomycin). We used a live MRSA cell assay that screened for both interference with vra expression and cell growth in the presence of subinhibitory Ox. We reasoned that since vra expression is autoregulated by the proteins encoded in the vra operon, screening for inhibition of Ox-induced vra expression would likely identify molecules that interfere with Vra protein activity. To this end we used a biosensor consisting of a transcriptional fusion between the vra operon promoter (Pvra) and a luciferase gene cluster (luxABCDE) expressed in USA 300 MRSA strain 923. From screening >26,000 small molecules we identified 9 lead compounds (3 from Prestwick and 6 from Life Chemicals) that act as synergists of Ox and inhibit vra operon expression in MRSA strain 923 as determined by an RT-PCR assay for vraR. In the R21 phase, we propose to further validate these lead compounds for Ox synergy against a large number of genetically diverse clinical MRSA strains, confirm the hits as true Vra effectors and identify probable alternate targets in genetic assays. In the R33 phase, we will further validate targets, improve the activity of the hit scaffolds, evaluate toxicity, PK/PD parameters in mice and ultimately test efficacy with Ox in our rodent models of lung and skin infection. Thus, the Specific Aims of this proposal are: R21 Aim 1. We will establish the scope of lead compound activity against clinical MRSA strains of diverse genetic background. Specifically, we will test our 9 lead compounds for inhibition of vraTSR expression and synergy with Ox. We will also test our hypothesis that vraTSR expression inhibitors will cross-potentiate vancomycin and daptomycin. Aim 2. Use ligand-based strategies to identify lead inhibitors from the best scaffold of compounds that synergize with Ox. We will complete structure-activity relationship analyses of top hits and structurally related compounds to identify the best scaffold for initial expansion Aim 3: Target Confirmation/Identification: Test our hypothesis that Vra S, R, or T are targets of the compounds that synergize with Ox. We will determine whether lead compounds bind to Vra S, R or T (using surface plasmon resonance (SPR) or interfere with the phosphorylation or dimerization of VraS and VraR or the DNA binding activity of VraR. In parallel, alternate targets of compound inhibition will be explored by using selection mutagenesis and microarray transcriptional analysis to identify the underlying stress pathways imposed by a compound. R33 Aim 4. Optimization of confirmed MRSA inhibitors by ligand- and structure-based design strategies and scaffold expansion through synthetic development. Improve the activity of the hit scaffolds already identified and identify new hit scaffolds based upon similar features to those identified. We will also test our working hypothesis that compounds with improved activity and features can be designed and synthesized using ligand-based virtual screening techniques, including similarity and scaffold searching, and more advanced shape and electrostatic matching, with synthetic optimization to enhance activity. Aim 5. Preclinical validation of the best leads through initial in vitro testing (microsomal stability, cytotoxicity, serum protein binding), and subsequently in animal models: PK/PD, toxicity, half life, efficacy in skin and lung infection models. We plan to improve inhibitor stability through a metabolic stability-SAR guided structure based design approach, while maintaining synergistic potency through correlation with the mechanistic SAR.